Evaluation of the Requirements and Critical Features of a Drone-Deployed AED Network to Improve Community-Level Survival after OHCA

Abstract
Out-of-hospital cardiac arrest (OHCA) affects over 350,000 Americans annually and survival rates are very
low. For every 1-minute delay in achieving return of effective heart function after collapse, the chance of
survival drops by 10%. Bystanders can aid in the emergency treatment of OHCA victims by performing chest
compressions and by using automated external defibrillators (AEDs). However, current bystander use of static
AEDs is very low and defibrillation is primarily administered by first responders and emergency medical
services (EMS) whose median arrival time (8 minutes) is too late to save most OHCA patients. Using a drone
to deliver AEDs to OHCA victims within 3 to 5 minutes of the 911 call is an exciting new concept that is based
on current technical capabilities of drones. Early work with simulation models has demonstrated the potential of
a strategically designed drone network to deliver an AED to an OHCA substantially more rapidly than EMS can
achieve. However, these early simulations assumed complete effectiveness of AED use when delivered to an
OHCA scene without considering the bystander variables. It is well-known that bystanders may hesitate to
perform CPR and to apply an AED, and that select demographic and neighborhood factors (age, sex,
race/gender, education) may be predictive of such treatment variability. The time it takes a bystander to extract
an AED and apply it successfully in OHCA may critically impact overall survival gains from timely drone AED
delivery. An accurate understanding of potential treatment effectiveness should account for expected
bystander performance. The overarching aim of this application is to utilize data science and simulation
research to estimate end-user performance and treatment-effectiveness of a drone network accounting for
community, first responder, and EMS performance. Aim 1 will determine the optimal placement of drone
stations to ensure timely AED arrival in high-OHCA risk geographic areas (within 3 to 5 minutes) across North
Carolina. Aim 2 will define and determine the association of community phenotypic clusters on OHCA
treatment patterns in high-incidence NC communities. Aim 3 will use simulated drone AED OHCA scenarios to
define drone-AED-bystander treatment intervals among community phenotypic clusters (e.g., minority, rural,
low education, elderly) in high-OHCA risk NC neighborhoods. Results from Aims 2 and 3 will be used to refine
our optimization model (Aim 1) to estimate treatment effectiveness and efficiency. The proposed work will be
carried out under the direct supervision of Dr. Starks mentorship team: mentor (Dr. Daniel Mark), co-mentor
(Dr. Christopher Granger), and her advisory team (Drs. Billy Williams and Graham Nichol). This K23
application with the support and guidance of her mentorship team and advisory committee will position Dr.
Starks to eventually lead independent NIH funded studies focused on community treatment of OHCA, including
developing/testing interventions to improve AED use in OHCA and pragmatic clinical trials to determine if our
model-based EMS drone AED delivery system measurably improves empirical outcomes in OHCA victims.

Public health relevance
Project Narrative In the United States, approximately 350,000 people suffer out-of-hospital cardiac arrest per year; the best chance of survival is when defibrillation occurs within 3 minutes. This proposal seeks estimate bystander AED performance in high-risk geographic areas to determine the treatment effect of a drone AED network. Our research has the potential to significantly improve treatment and survival for OHCA.